Anxiety as a Mediator of the Relationship between Implicit Bias and Health Care Disparities: A Multi-Method Approach

Project summary. Health disparities are a matter of grave public health significance, and advancing
scientific understanding of the causes of health disparities is part of the National Institute of Minority Health
Disparities strategic plan. Racial health disparities have complex etiologies and correlates, but remain when
controlling for other social determinants of health and patient factors such as treatment refusal. Residual
disparities reflect differences in provider treatment of White and minority patients. One factor contributing
to disparate treatment of minority patients is provider implicit bias—non-conscious biases that alter behavior.
Provider implicit bias predicts subtle behavioral differences in interactions with minority patients, including more
anxiety-related word usage, more negative affect, and different nonverbals. These provider behaviors
predict lower patient satisfaction and adherence, with health and mortality consequences. Despite haste
to target implicit bias in disparity reduction interventions, the research on implicit bias reduction efforts is weak
and mixed; most studies show no impact of implicit bias interventions. Furthermore, implicit bias is difficult to
measure and demonstrates only moderate test-retest reliability. Nevertheless, there are clear public health
implications of even weak effects of implicit bias when considering the number of people affected.
Effects of implicit bias on disparities may be clarified by articulating and examining more complex models
of the relationship between implicit bias and provider behavior. This proposal examines intergroup anxiety
(anxiety that manifests in interracial interactions in response to negative expectations) as a mediator of the
relationship between implicit bias and provider behavior. It is well known that anxiety affects behavior in the
general population, and provider anxiety impairs patient outcomes, such as satisfaction and adherence,
but no research has examined the effects of intergroup anxiety on provider behavior. To ensure a
comprehensive analysis of the innovative association between intergroup anxiety and provider behavior, we
propose to measure both constructs at multiple levels. We will assess anxiety through both self-report affect
and physiology. We will examine three classes of behavior: verbal behavior (anxiety-related word use), global
behavior (warmth) and nonverbal behaviors (using indicators identified by expert tape analysis—recent pilot,
and aim 1). We will conduct this research in medical students (N=70). Medical school is a key window-of-
opportunity when biases may be more malleable, students are accessible, and training is expected. Many
medical schools use implicit bias reduction trainings to decrease disparities, but intergroup anxiety may
represent a more consistently alterable and easy-to-measure construct. Disparity-reduction trainings based on
evidence-based models such as the proposed may have large impacts on health disparities; my long-term
career goal is to study factors that contribute to health disparities across multiple social determinants of health
and design, test, and disseminate interventions on evidence-supported targets such as intergroup anxiety.

Public health relevance
Project Narrative Despite explicit beliefs in social equity and justice, healthcare providers often behave differently when interacting with Black versus White patients, contributing to racial disparities in healthcare outcomes such as lower patient satisfaction and adherence with medical recommendations. Scientific attention has turned towards understanding the role of implicit provider biases in this problem, but implicit bias is difficult to directly measure and intervene upon, and findings are often moderated by other variables. In this project, we examine provider intergroup anxiety as a mechanism by which bias may change behavior in interracial provider-patient interactions to shed light on a potentially important intervention target for efforts to reduce disparities.